Translational Training in Addiction

PROJECT SUMMARY/ABSTRACT
This proposal seeks competitive renewal (years 16-20) of the UAMS NIDA T32 training program “Translational
Training in Addiction.” Spanning six academic departments and three Colleges, the program provides multi-
level, cross-disciplinary, team science training that spans the translational research gamut from animal models
to population-based approaches to solutions to curb or halt drug addiction. With program priorities of training
innovation, diversity, connectivity, and outcomes, this renewal seeks further support for a program of training
excellence that is dynamic and evolving in response to the rapidly changing societal, legislative, research,
clinical, and community responses to addiction. The program Co-Directors, Governance and Steering
Committees, and external evaluators/advisers enact the roles of program administration, connectivity, and
oversight. A program evaluation plan is based on progress towards eight training objectives: (1) foster a shared
knowledge of the broad societal and health impacts of drug use disorders, and of the diversity of engaged
scientific disciplines, (2) provide an individualized path to diverse addiction impact career areas and maximize
post-training outcomes, (3) foster diversity as a strength for maximizing program impact, (4) provide career
building environments emphasizing interdisciplinary, team science, and translational research, (5) innovate
advances in training approaches to research ethics, professional development, and program connectivity, (6)
enhance awareness of and impact on translational outcomes, (7) evaluate both bibliometric and translational
science benefit outcomes of the program, and (8) foster the engagement of physicians and other clinicians in
the career building processes of the program. A Progress Report details significant outcomes for each
objective; quantitative and qualitative data support the claim of program excellence in the current funding cycle.
Continued support is requested for three levels of trainees involving three predoctoral students, four
postdoctoral fellows, and four annual M2 summer addiction research interns, complemented by institutional
support of one annual PGY3 psychiatry resident. Program-wide courses, faculty-facilitated seminar and
presentation series, professional development lectures and workshops, and elective mentored research
training emphasis/impact areas would support translational research training opportunities across the spectrum
of T1 to T4 translational science. Mechanisms of trainee and program evaluation will focus on both scientific
bibliometric and translational human health and society benefit indicators of program impact. Other feedback-
driven new initiatives will include a redesigned grant writing skill development course and workshop, as well as
a well-developed leadership succession plan. Significant institutional commitment and resources support the
accrued value and continued success of the training program.

Public health relevance
PROJECT NARRATIVE The current and future success of science in solving the drug addiction problem is dependent on collaborative partnerships between diverse researchers, clinicians, and affected communities that deliver discovery to addiction prevention and clinical care. Attaining this goal is increasingly dependent on interdisciplinary, team- based, clinical and community translational research and the ultimate objective of this training program is to develop this next generation of addiction investigators. As the sole NIDA T32 training program at the only academic medical center in the state of Arkansas, the proposed program seeks to use training and career development to meaningfully impact the immense public health problem of drug addiction at both the national, regional, and state levels.